Spreading Depolarizations and Perfusion in Non-traumatic Spinal Cord Injury

Cervical spondylotic myelopathy (CSM) is the most common cause of spinal cord damage in older adults. It is
characterized by physical compression of the spinal cord and often progresses gradually over months to years,
manifesting as weakness, numbness, and pain. Because it is a disease that disproportionately affects an aging
population and leads to decreased quality of life, it has a high relevance to Veterans. Many patients with CSM
have favorable outcomes after surgical intervention, but opportunities to improve outcomes through mechanistic
understanding of the disease process and improved diagnostic markers would be beneficial to improve diagnosis
and patient management, potentially leading to improvements in therapies. This project aims to examine the role
of spreading depolarization and perfusion deficits in the context of CSM in preclinical animal models. Spreading
depolarization (SD) is an abnormal wave of ionic and electrical that propagates through central nervous system
tissues after an insult. While SDs have been well-established and characterized after acute physical trauma,
they have not been investigated with persistent or repetitive physical compression of the spinal cord that is the
hallmark of CSM. Further, SDs and underlying perfusion deficits are tightly coupled. Neurons with sufficient
oxygen and glucose can recover from SDs, but neurons that are lack sufficient metabolic substrates have a high
likelihood of being irreparably damaged by SDs. This project will use an animal model and electrophysiological
recordings to characterize SD events in the spinal cord in the context of continuous or dynamic physical
compression (Aim 1). In parallel, it will examine the perfusion deficits in the spinal cord using MRI or intraspinal
pressure sensors in the context of a clinically relevant animal model of CSM with progressive spinal cord
compression (Aim 2). Collectively, these studies will elucidate the mechanisms of spinal cord damage in CSM
and may provide new avenues for diagnostic markers. Detecting abnormal perfusion noninvasively with MRI has
a clear translational path for subsequent clinical studies of CSM patients. The team of investigators on this project
have individual expertise in all of the different subject areas, and their combined multi-disciplinary approach to
these studies will collectively examine a new research area with potential high clinical relevance and translational
opportunities.

Public health relevance
The Department of Veteran’s Affairs provides care for nontraumatic spinal cord disorders such as the degenerative disease cervical spondylotic myelopathy (CSM). CSM is the most common cause of spinal cord dysfunction in older adults, causes significant functional impairments and reduced quality of life, and is a risk factor for subsequent traumatic spinal cord injury. The current proposal seeks to understand the spinal cord damage incurred in CSM by examining the underlying electrical and perfusion dysfunctions in an animal model. These studies will elucidate crucial links between compression of the spinal cord and the resulting cell damage and neurologic dysfunction. The results of this study will help establish causal factors of CSM and will offer new approaches for detecting, monitoring, and guiding interventions to help improve the lives of Veterans with this condition.